PILOT PROJECT PROGRAM

The overarching goal of this application is to complete the establishment of a thriving, stand-alone Lung Biology Center (LBC) of Biomedical Research Excellence at Dartmouth, and thus to advance the understanding and treatment of lung disease. We have recruited a critical mass of faculty investigators with strong track-records of scientific productivity and extramural funding. To sustain a trajectory of novel, highimpact, multi-disciplinary and translational research projects, our Pilot Project Program (P^) will: 1) Encourage the development of preliminary data to open up new research opportunities, refine hypotheses, and strengthen proposals to compete for extramural support; 2) Enhance collaborative and interdisciplinary research, engaging current LBC members and recruiting additional faculty at Dartmouth and our IDeA partners; 3) Deepen our reservoir of translational and clinical research projects, providing funds to physician scientists and their collaborators; 4) Nucleate the submission of multi-investigator center and programproject grants; and 5) Support the professional development of our faculty through mentoring of junior faculty and physician scientists. Under COBRE II, we leveraged $377K of pilot support into $6.2M of extramural funding. Building on this model, have designed an inclusive RFA and a rigorous multi-stage review procedure to award P^ grants under three mechanisms: 1) Mentored Basic or Translational Studies for junior faculty; 2) Collaborative Basic or Translational Studies for interdisciplinary studies; and 3) Translational and Clinical Studies, led by an MD or MD/PhD faculty investigator. Administrative Core supervision will assure compliance with NIH and institutional rules and provide comprehensive evaluation of each project and ofthe Program as a whole. The P^ awards will accelerate the pace of research and support the intellectual vitality and self-renewal of the LBC. They will also foster interdisciplinary, multi-investigator, and clinically relevant research. Thus, the P Program is closely aligned with COBRE, IDeA, and NIH objectives. By engaging existing and new faculty and supporting transformative research, it will directly enhance the identity and scientific impact of the Dartmouth Lung Biology Center.

Public health relevance
Infectious respiratory diseases are the third leading cause of death in the U.S. The studies described in this application will lead to a better understanding of how opportunistic pathogens, including Pseudomonas aeruginosa, cause chronic respiratory infections, and to new drugs / therapies to treat infectious respiratory disease.